P/O CRYOPRESERVED NO-SPIN HEPARG (8M CELLS/VIAL)

The purpose of this is to acquire primary human hepatocytes for chemical toxicity screening in 2D and/or 3D as part of a large scale collaboration between the US EPA and the NIEHS/DNTP, including but not limited to the Tox21 MOU.